Developing a parent-adolescent relationship abuse prevention intervention for pediatric primary care

ABSTRACT
Adolescent relationship abuse (ARA), defined as physical, psychological, cyber, sexual abuse, or stalking in
the context of a teen dating relationship, is pervasive and associated with myriad negative health outcomes for
youth. Parental monitoring of adolescents’ interpersonal relationships and activities is a powerful and
modifiable protective factor to prevent ARA. Promising parent-adolescent interventions have emerged;
however, some implementation challenges may exist particularly with recruiting and retaining parents. A
potentially important setting to engaging parents and adolescents in ARA prevention is pediatric primary care,
as parents accompany adolescents to annual well-child visits. Our team conducted interviews with 60
adolescents, parents, and healthcare providers who stated ARA is not currently discussed during well-child
visits and an intervention around this topic is needed for primary care settings. However, a recent systematic
review of sexual health and ARA interventions in primary care identified only one effective program focused on
ARA, which was designed for older adolescents in school-based health centers and has no content around
parental monitoring. Our goal for this R21 proposal is to first develop a brief ARA prevention intervention for
middle-school aged adolescents (11 to 15) and their parents for the pediatric primary care setting and then
conduct a pilot trial with parent-adolescent dyads. We will use the Capability, Opportunity, and Motivation
Model of Behavioral change (COM-B) to guide intervention development, which describes how capability
(knowledge about dating/ARA, self-efficacy to prevent ARA), opportunity (opportunity to engage in dating/ARA
parental monitoring, resource utilization), and motivation (interest/desire to engage in dating/ARA parental
monitoring) drive behavioral change. In Aim 1, guided by a community collaborative, we will use an intervention
mapping approach to develop a provider-delivered ARA prevention intervention to be implemented within
pediatric primary care settings. Informed by Aim 1 results, we will conduct a pilot trial with 55 parent-adolescent
dyads within 4 pediatric primary care clinic sites, with the primary outcomes of assessing trial feasibility and
intervention acceptability. Secondary exploratory outcomes will be: 1) behavioral change objectives pre and
post (1, 6 months) intervention through parent and adolescent surveys; and 2) implementation barriers and
facilitators using Proctor’s implementation outcomes framework through parent, adolescent, and provider
interviews. This proposal leverages a multidisciplinary team of violence prevention and family-based
intervention experts, as well as violence prevention leaders from Futures Without Violence and the Centers for
Disease Control and Prevention. Results from this study will inform a future R01 proposal to conduct a fully-
powered hybrid type 1 trial to test the effectiveness of the intervention, as well as collect implementation data.

Public health relevance
PROJECT NARRATIVE Parents can help protect their adolescent children from experiencing adolescent relationship abuse (ARA), especially through parental monitoring. Parents accompany adolescents to well-child visits; therefore, the pediatric primary care setting is an ideal location to deliver an ARA prevention intervention. In this proposal, we will create and pilot test an ARA prevention intervention for middle school age adolescents and their parents, which can be delivered by healthcare providers in pediatric primary care settings.